Pharmacologically Enhancing the Modification of Strong Modification Resistant Memories

Therapeutic methods designed to attenuate maladaptive emotional memories are not satisfactorily effective.
Disruption of the reconsolidation process has been proposed to be a powerful method to attenuate strong
memories in psychopathologies such as PTSD, but numerous studies indicate that strong memories are resistant
to becoming destabilized following reactivation. Because of this, viable treatments to therapeutically attenuate
maladaptive memories by taking advantage of the phenomenon of reconsolidation updating have yet to be fully
developed. Here, we present preliminary data detailing the ability of the FDA-approved drug simvastatin (SV) to
enhance the retrieval-dependent destabilization of a strong fear memory. Our proposed experiments will
investigate the potential clinical utility of SV, as well as determine the mechanism of action by which SV renders
typically modification-resistant circuits modifiable. This work has broad applicability because it investigates both
the mechanisms gating induction of plasticity in difficult-to-modify circuits and potential therapeutic methods to
intervene on these states. Aim 1: Our preliminary data indicate that 5 days of SV treatment prior to fear memory
retrieval enhances destabilization of a strong fear memory. Therefore, we propose to assess the ability of SV to
enhance destabilization of a strong fear memory by using an animal model of PTSD in conjunction with FDA-
approved reconsolidation disruptors. Aim 2: SV has been reported to enhance GluN2B surface localization via
inhibition of its phosphorylation-driven endocytosis. To determine if inhibition of this process is sufficient to
enhance destabilization of a strong fear memory, we generated lenti viruses to express GluN2B(E1479Q) within
α-CaMKII positive BLA neurons in a doxycycline-dependent manner. This allows us to increase surface
expression of GluN2B after the memory has consolidated by manipulating the same phosphorylation-driven
endocytosis pathway that SV is reported to affect. We show that expression of GluN2B(E1479Q) in the mouse
BLA is sufficient to enhance destabilization of a strong fear memory, supporting the hypothesis that SV enhances
plasticity by enhancing synaptic localization of GluN2B. Therefore, we propose a suite of biochemical and
electrophysiological analyses to determine precisely how SV alters BLA GluN2B trafficking, neurotransmission,
and plasticity. Aim 3: In this aim, we will determine whether SV exerts its mechanism of action through inhibition
of HMG-CoA reductase (HMGCR) pharmacologically by utilizing other statins, and genetically by conditionally
and acutely knocking out HMGCR in Floxed-HMGCR mice. Investigating the mechanism of action of SV may
lead to discoveries that not only have the potential to affect current therapeutic practice for PTSD, but also for
other disorders for which their etiologies involve modification-resistant neuronal circuits (e.g., depression and
chronic pain). By advancing our understanding of circuit stability and our ability to modify previously modification-
resistant traces, our proposed experiments may lead to the development of novel therapeutic strategies to
attenuate pathological symptoms and improve the health of patients suffering from a variety of disorders.

Public health relevance
Dysregulation of the fear system is associated with many psychiatric disorders underscoring the need for developing better treatments for pathological fear. This project aims to identify the mechanisms that contribute to the maintenance of pathological fear and provide the basis of a strategy for attenuating maladaptive fear memories.